Natural killer cells subvert immune checkpoint therapy of tumors

Abstract
Since natural killer (NK) cells can kill tumor cells that also stimulate NK cell production of
cytokines, there is intense current interest on how to harness NK cells to advance
immunotherapy of cancer. Most strategies guiding such work focus on markedly enhancing NK
cell responses to tumors. However, our understanding of NK cell biology in the context of
immune checkpoint therapy (ICT) of cancer is poorly understood. Contrary to expectations, here
the applicant’s laboratory presents preliminary data indicating that antibody-mediated NK cell
depletion or genetic absence of NK cells enhanced ICT in mice, suggesting NK cells subvert ICT.
Moreover, transfer of NK cells into the tumor itself in mice genetically lacking NK cells restored
subversion of ICT. Furthermore, anti-NKG2D also enhanced ICT. Finally, the applicant provides
evidence from human tumor databases that a similar process may be occurring in patients.
Thus, NK cells subvert ICT and NKG2D appears to be involved in this process. Therefore, the
Specific Aims of this proposal are to: 1) Elucidate effector mechanism(s) by which NK cells
constrain ICT; 2) Evaluate contribution of NKG2D; and 3) Translate mouse findings to human
tumors. Taken together, this proposal will lead to increased insight on the role of NK cells in ICT
and will help guide new strategies to modulate NK cells for improved cancer immunotherapy.

Public health relevance
Project Narrative This project deals with natural killer (NK) cells which are immune cells that can control tumors and how they participate in a new type of cancer treatment termed immune checkpoint therapy which harnesses other cells in the immune system to attack cancer. Contrary to expectations, the Yokoyama lab presents preliminary evidence that NK cells subvert immune checkpoint therapy. The current proposal seeks to better understand how NK cells do this to better understand basic NK cell biology and to guide new strategies to modulate NK cells in cancer treatments.